Characterizing the molecular mechanisms of centriole duplication and elongation

PROJECT SUMMARY/ABSTRACT
Centrosomes are organelles used to build microtubule-based protein machines, including mitotic spindles
and cilia. At the centrosome core lies a pair of ‘mother-daughter’ centrioles, barrel-shaped structures that
act as the duplicating elements of the organelle. Normally, the centriole pair duplicates only once each
cell cycle and, during mitotic entry, centrioles recruit a shell of pericentriolar material (PCM) from which
microtubules grow. Not only are they one of the largest protein complexes in eukaryotic cells but one of
the most ancient of organelles, and have fascinated cell biologists since their discovery in the late 19th
century. During the past 25 years, advances in imaging, proteomics and functional genomic screens have
led to an explosion of discoveries in the centrosome field. At present, we have a complete inventory of
the proteins comprising centrosomes. In our model system, Drosophila, centrosomes assemble from a
surprisingly small number of components (approximately 20). Despite these advances, many important
questions remain unanswered. For example, although Polo-like kinase 4 (Plk4) is recognized as the
conserved master-regulator of centriole duplication, it is not known how Plk4’s catalytic activity is regulated
specifically on centrioles. How are mother centrioles restrained to spawn only a single daughter once per
cell cycle? What are the phosphorylation targets of Plk4 and how do the modified components then
assemble a centriole? How is centriole length controlled? Understanding these processes at the molecular
level is important because alterations in centrosome structure or number cause a number of serious
pathologies, including birth defects, ciliopathies and cancer. Plk4 has been the centerpiece of our research
program because it is both necessary and sufficient to induce centrosome overduplication (amplification)
when overexpressed, a scenario observed in cancer cells. We have published a series of studies that
have defined Plk4 structure, regulation and identified several of its substrates. Notably, Plk4 utilizes
multiple mechanisms of control to restrain its activity and prevent rampant centrosome overduplication,
using an elaborate combination of autophosphorylation, ubiquitination and autoinhibition. We continue to
pursue two overarching goals in this renewal of R35 R35GM136265: 1) identifying the molecular
mechanisms that suppress centrosome amplification, and 2) characterizing the inherent mechanisms that
govern centrosome function and duplication. Building on our progress during the past four years, we
propose to continue our studies that will define the mechanisms underlying four sequential steps in the
centriole assembly process. Specifically, we will determine (i) how a single site of daughter centriole
assembly is selected on mother centrioles, (ii) the composition of the pre-procentrioles, how it forms and
its role in centriole duplication, (iii) how Plk4 induces nascent daughter centriole (procentriole) assembly,
and (iv) how centriole length is controlled to promote elongation and maintain a terminal length.

Public health relevance
PROJECT NARRATIVE The proposed research is relevant to public health because it focuses on discovering and characterizing the evolutionarily conserved mechanisms that control the assembly of centrosomes – a process that, when dysfunctional, contributes to ciliopathy, birth defects and tumorigenesis. Thus, the project is relevant to a part of the NIH’s mission because it will enhance our knowledge as to the etiology of numerous centrosome-related human diseases.